Nuclear-Metabolic Interplay in Down syndrome

Abstract
Down syndrome (DS) is a complex genetic disorder with significant physical, cognitive, and behavioral
manifestations. Individuals with DS are also more likely to develop certain health conditions including those
related to dysfunctional metabolism, such as obesity and diabetes. Further, converging lines of evidence suggest
that cellular metabolism is a critical regulator of neurodevelopment, and that metabolites play key roles in
regulating neural progenitor cell (NPC) proliferation fate specification required for proper brain development.
Despite this, studies have largely overlooked the influence of cellular metabolism on the neurodevelopmental
deficits that contribute to DS pathophysiology. This study aims to comprehensively investigate the intricate
nuclear-metabolic interplay in DS. Our multifaceted approach utilizing human stem cell and mouse models will
decode the molecular, cellular, and tissue level role of cellular metabolism on the brain etiologies observed in
DS. We aim to characterize and modulate the nuclear-metabolic axis at three levels during neurodevelopment:
1) glycolysis, 2) lipid/cholesterol metabolism, and 3) histone acetylation. Findings from this study will provide
critical insights into the mechanisms underlying aberrant brain development in DS and will uncover promising
therapeutic strategies to ameliorate the impact of dysfunctional neurogenesis. Further, our work will shed light
on the broader understanding of the nuclear-metabolic interplay during fate specification, differentiation,
proliferation and brain morphogenesis. Ultimately, this research will provide the blueprint for exploring the role
of the nuclear-metabolic axis broadly in neurodevelopmental disorders, beyond DS, and provide unexplored
therapeutic avenues to improve the lives of individuals living with this disorder.

Public health relevance
Project Narrative Down syndrome (DS), caused by triplication of chromosome 21, is the most common intellectual disability disorder affecting more than 250,000 individuals in the United States alone. Abnormalities in brain development and metabolic dysregulation are hallmarks of DS, and emerging evidence suggests that metabolism plays a key role in brain development, yet the consequence of altered cellular metabolism on brain development in the context of DS is unknown. This project will support the NIH’s mission to seek fundamental knowledge about the nature of living systems and apply that knowledge to advance human health by exploring the consequence of altered cellular metabolism on neural progenitor cell proliferation and fate specification in brain development to gain insight into the pathogenesis of DS and enhance health outcomes for individuals suffering from the disorders.